CE-22-010 Linking Individuals Needing Care for Substance Use Disorders in Urban Emergency Departments to Peer coaches (LINCS UP)

PROJECT SUMMARY: Deaths from drug overdose have risen to record levels since the onset of the COVID-
19 pandemic, disproportionately impacting Black individuals and people experiencing homelessness.(2-6)
Fewer than one-third of the 8.3 million individuals living with an illicit drug use disorder in 2019 reported
receiving treatment.(7) Telemedicine services have increased access to care for many patients living with
substance use disorders (SUD), but the long-term role of this treatment approach in SUD care is uncertain.(8-
11) Multifaceted strategies are needed to build recovery capital and link vulnerable individuals to recovery
resources.(12) Emergency department (ED) visits are an opportunity to screen for SUDs, initiate treatment,
and link to recovery resources.(13, 14) Observational studies have noted that consultation with a peer recovery
coach (PRC) was well-received in EDs, with high rates of engagement and satisfaction.(15, 16) PRCs facilitate
conversations allowing patients to express their ideal pathway to recovery, provide linkage to services across
the social ecology,(17, 18) and follow up to support recovery, including re-linkage to resources as needed.
Nonetheless, their role in ED screening and linkage to resources, including the potential role of telemedicine,
has not been rigorously evaluated.(13) The objective of this prospective study is to develop a robust evidence
base supporting a novel approach to embedding peer recovery coaches in the ED setting to link patients with
an illicit SUD to recovery support services. Investigators will conduct a Hybrid Type 1 effectiveness-
implementation trial at Grady Memorial Hospital, a large, urban level 1 trauma center that serves a
socioeconomically vulnerable and racial minority population with a high rate of substance use.(25, 26) The
implementation component will be guided by the EPIS framework,(28, 29) and the effectiveness component
will include a randomized controlled trial enrolling 600 subjects across three arms: in-person peer coaching
with linkage to recovery support services and callbacks, telemedicine-based peer coaching with linkage and
callbacks, or usual care. The public health impact of ED PRCs will be measured across the dimensions of the
RE-AIM framework.(27) This work builds established partnerships with Georgia Council on Substance Abuse
and other local community organizations to implement ED PRCs while uniquely integrating and evaluating their
utility. Results will inform other EDs considering a peer recovery coach program for patients presenting with
SUD-related conditions. By utilizing telemedicine, this model will be rapidly scalable and readily implemented
at other facilities. This study’s focus directly aligns with the CDC’s funding priority to support interdisciplinary
teams implementing evidence-based scalable approaches for linking individuals from communities
experiencing a disproportionate burden of illicit substance use and overdose, such as the racially, ethnically,
and economically diverse patient population seen in the Grady ED.

Public health relevance
PROJECT NARRATIVE: Multifaceted strategies are needed to stem the tide of the drug overdose crisis, linking vulnerable individuals to recovery resources and helping them to build recovery capital. In this Hybrid Type 1 effectiveness-implementation trial implementing peer recovery coaches both in-person and via telemedicine at a large, urban level 1 trauma center, investigators will study the process of peer recovery coach implementation and patient- and community-oriented outcomes resulting from the program. Results will inform other EDs considering their own peer recovery coach program, including rapidly scalable telemedicine- based programs.